Centering Those Engaged in Transactional Sex: A PrEP Innovation for Getting To Zero

Getting to Zero (GTZ) new HIV infections by 2030 is a public health priority. Increasing HIV prevention, self-
management, and harm reduction among at-risk populations is critical. HIV prevalence in sex workers is 12
times greater than the general population, highlighting the need for targeted prevention efforts. Increasing
optimal use of pre-exposure prophylaxis (PrEP) in this population will advance progress toward GTZ 2030.
Community empowerment interventions reduce HIV risk among sex workers because interventions are
collaboratively designed, implemented, and evaluated by the target population. A community-empowered PrEP
navigation approach may be feasible and acceptable among sex workers. One such approach is a group
healthcare model called Centering Healthcare (Centering), which originated as a group prenatal care model
and has since been modified for various patient populations. Centering's three core components: healthcare,
interactive learning, and community building, disrupt typical healthcare power hierarchies by creating a
respectful and collaborative interactive learning environment that honors group needs. The model's positive
impact links self-management goals and health assessment with interactive activities to foster health
promotion. Using an implementation science framework and building on Centering intervention
effectiveness, this study will be the first to evaluate whether Centering is feasible and acceptable for
PrEP education, navigation, and adherence among sex workers. Preliminary qualitative research with 39
sex workers in Chicago highlighted that stigma and healthcare discrimination dissuaded sex workers from
regularly accessing HIV prevention information, services, and treatment. In collaboration with sex workers and
a Community Advisory Board (CAB), we culturally adapted the Centering curriculum and facilitator's guide to
meet the stated needs of sex workers. Guided by an Exploration, Preparation, Implementation, Sustainment
framework (EPIS), the overall goal of this study is to expand on my formative research and evaluate if this
culturally adapted Centering PrEP (C-PrEP+) model is feasible and acceptable for addressing education,
navigation and PrEP adherence needs of HIV negative sex workers in Chicago. Specific aims of this study are
to 1. Produce an implementation plan for integrating C-PrEP+ into a Federally Qualified Health Care (FQHC)
system. 2. Conduct a pilot feasibility and acceptability trial of C-PrEP+. 3. Complete an evaluation of C-PrEP+
to document implementation barriers and facilitators. The research plan will be augmented by expert mentoring
and didactic research training at University of Illinois Chicago and University of California San Francisco. This
proposal, mentoring, and coursework will provide essential career development in: 1. Quantitative methods, 2.
Health intervention study design, preparation, implementation, and 3. Mixed-methodological evaluation. This
foundation will uniquely position the PI to lead a fully powered multi-site RCT to determine if C-PrEP+ is an
efficacious and sustainable model to address HIV prevention among sex workers.

Public health relevance
Public Relevance Statement There is an urgent need for innovative approaches that support the use of Preexposure Prophylaxis (PrEP), a daily pill preventing HIV that is empowering and user-controlled. Using a participatory implementation science framework, I will test whether an adapted and community empowered group healthcare model, Centering PrEP+, is a feasible and acceptable health system intervention to improve the health of sex workers and their clients by increasing PrEP adherence.